The NET Impact on Lung Epithelia in Cystic Fibrosis and Mucoobstruction

Abstract
Cystic fibrosis (CF) lung disease has fundamentally changed in the era of highly effective CFTR modulators,
but the inflammation mediating progressive lung destruction and bacterial infections remain major clinical
problems. Treatments for people with other mucoobstructive lung diseases are even more limited. Our
proposal will address the fundamental gap in our understanding regarding the molecular mechanisms by which
NETs contribute to airway damage and infection in mucoobstructive lung diseases. People with
mucoobstructive disease have high neutrophil extracellular trap (NET) burdens in their lungs. NETs are web-
like structures with a DNA backbone studded with immunomodulatory proteins (e.g., neutrophil elastase=NE).
NETs trap and kill microorganisms, however, we have demonstrated that NETs drive epithelial inflammation
and cause lung tissue injury. We postulate that NETs are critical mediators of inflammation and infection in
mucoobstructive diseases, but their role is unclear. We propose that NETs act through targeting of E-cadherin,
an epithelial junction protein that is bound to intracellular β-catenin, which can activate NF-κB signaling to
increase cytokines. In preliminary work, we demonstrated that NET exposure separately leads to: cleavage of
E-cadherin, activation of β-catenin and NF-κB, enhanced IL-1 signaling, leading to secretion of TNF-α and IL-8,
apoptosis, release of free iron and increased intracellular Pseudomonal (PA) density in primary human
bronchial epithelia. We have shown that alpha-1 antitrypsin (A1AT) mitigates many of these deleterious NET
effects. We discovered that the βENaC-Tg mouse model of mucoobstructive lung disease—with increased
lung NETs and delayed clearance of PA—have spontaneously increased: E-cadherin cleavage, TNF-α and IL-
8 homologues and apoptosis. In this proposal we will coalesce these individual findings into a cohesive
molecular mechanism and test our central hypothesis that A1AT inhibition of NET-mediated cleavage of E-
cadherin will limit inflammatory cytokine signaling, which will reduce epithelial apoptosis and lung PA density.
In Aim1, we will test our hypothesis that NET-mediated cleavage of extracellular E-cadherin in bronchial
epithelium activates β-catenin to translocate to the nucleus and activate NF-κB signaling that increases
inflammatory cytokines (IL-1 & TNF-α). In Aim 2, we will test our hypothesis that NETs drive TNF-α-induced
apoptosis of the bronchial epithelium, which releases iron to foster PA growth and infection. In Aim 3 we will
use our novel gene delivery tool to test our hypothesis that transplanted pulmonary macrophages will produce
continuous and local hA1AT that decreases NET-driven NE activity, E-cadherin cleavage, inflammatory
cytokine secretion, apoptosis and decrease PA infection in mucus obstruction. The impact of our study will be
to generate new insights into the fundamental biology of NET: epithelial interactions, which are critical to
driving pathogenesis in mucoobstructive lung diseases and generalizable to other NET-mediated diseases.

Public health relevance
Lay Abstract Lung damage in Cystic Fibrosis and other mucoobstructive lung diseases is caused by an exuberant immune response, but how this occurs is unclear. We will determine the ways in which immune cells cause lung injury and inflammation. Then we will ascertain if adding a naturally occurring protein, alpha-1 antitrypsin, can limit immune-mediated lung tissue damage and bacterial infection with Pseudomonas.